Investigation of the role of CuZnSod1 in sensing Cu-deficient conditions in Candida albicans

Project Summary
Copper (Cu) is an essential micronutrient for nearly all eukaryotic organisms. Cells must maintain a careful Cu
homeostasis to balance cellular needs while minimizing toxicity due to excess Cu accumulation. Fungi, such as
Candida albicans, must acquire, route, store, use, and continually monitor levels of Cu to thrive in human hosts.
To survive as a human pathogen, C. albicans must be able to withstand the manipulation of Cu metal
concentrations at the host-pathogen interface, forcing the fungi to rely on complicated Cu homeostasis pathways
to adapt to Cu-replete and Cu-depleted environments. Although commonly used as a treatment, fluconazole is
fungistatic, merely inhibiting growth of C. albicans and increasing the risk of developing resistant strains.
Fluconazole induces a Cu-deficient response in C. albicans, despite an increase in total Cu levels compared to
untreated cells. The Cu-deficient response includes the induction of the Cu-import gene CTR1, repression of the
Cu exporter CRP1, and a switch in expression of cytosolic superoxide dismutase from CuZnSod1 to MnSod3,
controlled by the transcription factor Mac1. Mac1 is regulated by Cu levels in the cell, binding Cu ions under Cu-
replete conditions and binding DNA under Cu-deficient conditions. Despite understanding the metalloproteins
involved in the Cu-deficient response, there are still numerous gaps in our understanding of the response. It is
known that Mac1 must lose its Cu ions to bind DNA; however, the molecular basis for activation, including the
discrete entity involved, is unknown. The work described within this proposal seeks to further illuminate our
understanding of the Cu-deficient pathway of Cu homeostasis in C. albicans by investigating the role of
CuZnSod1. CuZnSod1 has been primarily characterized its role as global antioxidant, removing reactive oxygen
species; however, there are novel roles proposed for Sod1 in sensing the Cu levels of the cell and participating
in the Cu homeostasis response by directly activating Mac1. Here, I aim to probe the location and metalation
state of CuZnSod1 under fluconazole-induced Cu-deficient conditions and characterize the conditions for a direct
interaction between CuZnSod1 and Mac1, using biophysical techniques. Collectively, this work will allow us
further insight into the Cu-deficient homeostasis mechanisms of C. albicans and will allow us in the long-term to
apply this understanding to design more effective antifungal treatments exploiting metal-specific weakness to
increase potency and decrease changes of developing resistant strains.

Public health relevance
Project Narrative The copper (Cu) homeostasis mechanisms of Candidia albicans are critical for virulence in a human host, which creates niches of Cu-deficiency and excess as part of the immune response. Despite an understanding of the metalloproteins involved in Cu homeostasis, the mechanism of activation of the transcription factor that controls the Cu-deficient response is still unknown. We propose a wide array of biochemical techniques to investigate the location and metalation state of CuZnSod1 and its involvement in activating the transcription factor under Cu-deficient conditions induced by antifungal treatment; these results will advance our understanding of Mac1’s activation in C. albicans under Cu-deficient conditions and inform our understanding of developing better antifungal treatments exploiting metal-specific weaknesses.